Developmental Funds

DEVELOPMENTAL FUNDS
PROJECT SUMMARY/ABSTRACT
Rutgers Cancer Institute leverages funding from the CCSG and Institutional/Philanthropic support
to: 1) offer pilot project opportunities spanning basic, clinical, translational, and population science
research topics important to achieving Strategic Plan goals and aligning with catchment area
priorities; and 2) provide New Investigator Awards (NIAs) to cancer-focused research faculty new
to Rutgers (RU) and Princeton (PU) Universities and cancer-related research faculty established
at RU and PU. The ultimate goals are to increase cancer focus, integrate the five Research
Programs, and increase Member collaboration; awards are not synonymous and are in addition to
faculty recruitment start-up. The cancer institute leveraged its status as the only NCI-designated
Comprehensive Cancer Center in New Jersey to garner additional institutional commitment,
supplemented by generous philanthropic and State support, to establish four new Centers of
Excellence with annual budgets containing pilot award funding. Establishment of the Princeton
Branch of the Ludwig Institute for Cancer Research created additional opportunities to engage
PU members in immunology and metabolism research. Rutgers Cancer Institute’s process for
Developmental Funds administration has been enhanced (more frequent and detailed reporting)
and made more efficient over this grant period by utilizing two new decision support tools: the
InfoReady platform, a shared investment with Rutgers University, for automated award review
and reporting, and EVAL as the data warehouse for Developmental Funds awards and
demonstrable outcomes. The cancer institute’s oversight of Developmental Funds resulted in
strong ROI from its Pilot Project and New Investigator Awards in the form of publications,
extramural funding (peer-reviewed and non-peer-reviewed), clinical trials, training activities,
community outreach activities, bidirectional communication with the community, policy-related
activities, and commercialization activities. In this grant period, 28 pilot projects were awarded
and completed (resulting in nine peer-reviewed, extramural awards), and an additional 19 pilot
projects received funding in the last 12 months. Philanthropic funds were leveraged for a pilot
award to Eileen White allowing for the generation of preliminary data resulting in a successful
CRUK/NCI Grand Challenge application. Twelve New Investigator Awards over this grant period
resulted in eight peer-reviewed, extramural awards. In addition, after research leadership
endorsed Dr. Zhiyuan Shen to develop a P01 application, Libutti worked with the Rutgers
University Foundation to secure $2M in seed funding which enabled the generation of preliminary
data resulting in a successful P01 application (not a formal Pilot Project as defined herein).

Public health relevance
PROJECT NARRATIVE Not required per PAR-21-321 (Cancer Center Support Grants (CCSGs) for NCI-designated Cancer Centers (P30 Clinical Trial Optional)